Life Course Center for the Demography and Economics of Aging

PROJECT SUMMARY/ABSTRACT
This administrative supplement will support pilot work to quantify the effect of structural white advantage
(SWA) – policies and practices that provide greater resources and power to people racialized as white – on
cognitive health and ADRD risk among older US adults. The SWA framework complements structural racism
work by specifying the US context in which white racialization predominates the social hierarchy, providing insight
into how structural advantages promote cumulative cognitive health and the reduction of ADRD risk in later life
relative to multiple ethno-racial groups. Understanding the link between SWA and cognitive health may reveal
the effectiveness of policies/programs that target the distribution of resources to dominated groups (non-white)
to promote health equity. Additionally, the SWA framework provides a theoretical grounding to dissect potential
heterogeneities in cognitive reserve processes and outcomes among those racialized as white, providing
additional clues on how the intersection among structural inequities (e.g., SWA and classism) drives ADRD
disparities at the population level. A vital step in linking SWA to cognitive health is to operationalize and measure
SWA. The proposed project will 1) use administrative data to measure differential access to resources and power
between white and non-white groups and 2) apply confirmatory factor analysis to derive the SWA index. The
objective of the proposed project is to quantify the later-life cognitive health effects of SWA exposure in early
life and midlife for white, Black, and Hispanic participants from the nationally representative Health and
Retirement Survey. Results from the proposed supplement project will provide preliminary data for an R01
proposal that will examine relationships between SWA exposure and ADRD outcomes across additional NIA-
funded cohorts and assess for differential impacts by population and geography and intervening biological
mechanisms on cognitive function and ADRD risk. The R01 will also develop and test upstream structural
measures of the policies and practices that produce SWA to identify targets for potential interventions to reduce
ADRD disparities.
The proposed supplement aligns with the overall aims of the Minnesota Life Course Center for the Demography
and Economics of Aging (LCC) in three ways. (1) It brings together a new interdisciplinary team to support the
development of a promising junior scholar moving into research on the structural determinants of cognitive
health. (2) It will generate evidence of exposure to structural equities in early and midlife as a predictor of the
late-life risk of and racial disparities in ADRD risk among older adults. (3) Making the SWA indexes publicly
available aligns with the goals of the LCC’s External Innovative Network Core (the Network for Data-Intensive
Research on Aging [NDIRA]), which supports the use of novel data for research on population aging.

Public health relevance
NARRATIVE The proposed administrative supplement will support pilot work for a project to quantify the effect of structural white advantage (SWA) – policies and practices that provide greater resources and power to people racialized as white – on cognitive health and Alzheimer’s diseases and related dementias (ADRD) risk among older US adults. Understanding the linkage between SWA and cognitive health may reveal the effectiveness of policies/programs that target the distribution of resources to dominated groups (non-white) to promote health equity. Additionally, the SWA framework provides a theoretical grounding to dissect potential heterogeneities in cognitive reserve processes and outcomes among those racialized as white, providing additional clues on how the intersection among structural inequities (e.g., SWA and classism) determine ADRD disparities at the population level.